Role of Rare Human Genetic Variants in LRP1 on Aortic Aneurysm Formation

PROJECT SUMMARY
Abdominal aortic aneurysms (AAA) affect a significant portion of the population and are typically associated with
advanced age and atherosclerosis. Until now, no single gene has been identified as causative for AAA. Our
laboratory has initiated studies to characterize biochemical defects in a patient with severe presentation of AAA
in childhood. Two mutations on separate alleles were identified in the low density lipoprotein (LDL) receptor-
related protein 1 (LRP1) gene of the patient. The LRP1 mutations include a de novo mutation in a ligand binding
region and an inherited mutation in a β-propeller domain, a structure that is critical for LRP1 trafficking to the cell
surface. We predict that the functional deficits caused by each mutation are related to the physiological role of
the structural component where each mutation occurs. The LRP1 gene encodes a large endocytic and signaling
receptor that binds and traffics numerous ligands to lysosomal compartment for degradation. Mouse studies
reveal that selective deletion of LRP1 in vascular smooth muscle cells (smLRP1-/-) results in spontaneous and
fully penetrant aortic aneurysm formation. A major goal of these proposed studies is biochemical
characterization of the functional defects imposed by these mutant receptors, which will be critical to
defining mechanisms by which LRP1 regulates vessel wall homeostasis. Interestingly, bioinformatic
pathway analysis of quantitative proteomic results revealed excess signaling of the transforming growth factor-
β (TGF-β) pathway in both patient aortic smooth muscle cells and the aorta of smLRP1-/- mice compared to
controls. I hypothesize that loss of LRP1 function in the patient smooth muscle cells results from impaired
ligand binding due to the de novo LRP1 mutation and from inefficient delivery of LRP1 to the cell surface
due to the β-propeller domain LRP1 mutation. Furthermore, I hypothesize that the impact of these LRP1
mutations results in a loss of ability to attenuate the TGF-β signaling pathway. This hypothesis will be
tested in the following specific aims: (1) to define the mechanism by which mutations in LRP1 result in excessive
TGF-β signaling and (2) to determine the impact of patient LRP1 mutations on LRP1 trafficking. In vitro
experiments will determine if patient-specific LRP1 mutations alter TGF-β protein levels and signaling. Surface
plasmon resonance experiments will test if patient-specific LRP1 mutations result in defective binding of LRP1
to TGF-β, TGF-β binding partners, or molecular chaperones involved in LRP1 trafficking. Proteomic experiments
will define the LRP1 interactome in control and patient-derived aortic smooth muscle cells to further identify
defects in mutant LRP1 molecules. Finally, microscopy-based experiments will examine trafficking and recycling
properties of mutant forms of LRP1. This study will demonstrate the link between AAA and two independent
LRP1 mutations. The results will improve understanding of AAA formation to develop better treatments and
identify novel pharmaceutical targets.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysms are life-threatening weakenings in the vessel wall that often result in fatal blood vessel rupture. The goal of this project is to investigate the deficits caused by patient mutations in the first gene directly connected to abdominal aortic aneurysms. The results of this study will improve our understanding of abdominal aortic aneurysm formation in humans and will potentially lead to the identification of pharmacological targets for treatment of abdominal aortic aneurysms.